RELATIONSHIP OF MUSCULAR TONE TO TRANSIT IN THE HUMAN COLON

Colonic Motor Function will be assessed by simultaneously assessing colonic transit in response to known pharmacologically-induced changes of colonic tone in healthy individuals.